Multilevel Interventions to Reduce Harm and Improve Quality of Life for Patients on Long Term Opioid Therapy - Yale Resource Center (MIRHIQL-YRC)

Even after significant reductions in long-term opioid therapy (LTOT) prescribing for chronic pain nationally,
approximately 13 million US adults receive LTOT, putting them at risk for an array of harms often without
adequate benefit. Due to the often unfavorable risk-benefit profile of LTOT, current consensus guidelines
promote 1) continuous re-assessment of risk and benefit of LTOT and 2) reduction or discontinuation of LTOT
while supporting pain self-management strategies and non-opioid pain care when benefit no longer outweighs
harm. However, the guidelines lack crucial details--such as how to assess risk vs. benefit--hampering quality
improvement efforts. Clinical research has been slowed by lack of consensus related to important questions
such as: what is the threshold for determining that harm outweighs benefit in LTOT?, Should there be a new
diagnostic entity to characterize the clinical scenario of harm outweighing benefit?, and, if so, What are its
distinguishing characteristics? These research and clinical gaps translate into potentially poor quality pain care
for patients on LTOT, including low efficacy and heightened risk in a vulnerable population. In accordance with
RFA-DA-23-042, we propose the establishment of the Multilevel Interventions to Reduce Harm and Improve
Quality of Life for Patients on Long Term Opioid Therapy – Yale Resource Center (MIRHIQL-YRC) to address
the national opioid public health crisis via a focus on the oft-overlooked population of patients on LTOT for
whom risk may outweigh benefit but who do not have opioid use disorder. We propose an integrated, multi-
level structure of the MIRHIQL-YRC modeled after our high-functioning IMPOWR-YOU Research Center, with
a Community Steering Committee (CSC) at the hub and several smaller, agile workgroups focusing on specific
tasks but moving forward in a highly inter-related fashion. The CSC's impact will be bolstered by the presence
of partners historically left out of consensus-building projects: persons with lived experience and frontline
clinicians, groups for whom it is crucial the tools and other products developed are patient-centered, non-
stigmatizing, feasible and practical. Via this structure, the MIRHIQL-YRC, governed by the CSC, will pursue
four objectives: (1) Facilitating, through a variety of mechanisms detailed herein, the successful execution of
the companion MIRHIQL network R01 clinical trials; (2) Creating a risk-benefit decision tool to assist providers
in determining when opioids should be continued as prescribed, tapered, or tapered and discontinued; (3)
Creating a clinical definition, identifying associated symptoms/behaviors, and generating a screening
assessment for individuals on LTOT for whom harms outweigh the benefits; and (4) Validating the clinical
definition, associated symptoms/behaviors, and screening assessment in an independent prospective cohort
study. Our multi-disciplinary team with a long track record of successful collaboration and deep and broad
expertise in chronic pain and opioid management is exceptionally well-positioned to meet these objectives.

Public health relevance
Project Narrative Long-term opioid therapy (LTOT) has been demonstrated to cause harms and is often not effective in relieving pain; patients on LTOT may feel stuck when harms outweigh benefits and prescribers may not manage this scenario successfully. To address these issues, we propose creation of a Resource Center, led by a diverse, multi-disciplinary Community Steering Committee including persons with lived experience, to coordinate collaboration, resource sharing, and data harmonization of the MIRHIQL network's studies. Additionally, the Resource Center will pursue timely projects that will address critical gaps in the field: developing a risk/benefit tool for clinicians to use with patients; pursuing consensus on the need for a new diagnostic entity and its criteria; and validating the definition and elements of this new constructin a prospective cohort study.